Dispositional Negativity and the Pavlovian Control of Active and Passive Defensive Behavior

Individual differences in negative affect are captured by a relatively stable, transdiagnostic dimension known as
dispositional negativity, which can be decomposed into two correlated subcomponents: anxious distress (AD;
reflecting tendencies toward sadness and anxiety) and irritable distress (ID; reflecting tendencies toward
frustration and anger). The goal of this proposal is to provide training in behavioral experiments, computational
modeling, and functional magnetic resonance imaging (fMRI) methods that can be used to interrogate the
learning processes that underlie the subcomponents of dispositional negativity. Understanding the
neurocomputational basis of dispositional negativity is of central importance because it contributes to nearly all
forms of psychopathology and is strongly related to clinical prognosis, functional impairment, and economic
burden. The central hypothesis of the current proposal is that elevations in dispositional negativity reflect a
predominance of an inflexible Pavlovian learning system over instrumental behavioral control in aversive
contexts, with AD reflecting a Pavlovian bias to engage in passive avoidance, and ID reflecting a Pavlovian
bias to engage in active defense. Specifically, the aims of this project are to 1) demonstrate that passive and
active Pavlovian biases are differentially associated with individual differences in AD and ID; 2) characterize
the neural circuitry underlying AD, ID, and their associated Pavlovian biases; and 3) show that biases toward
active and passive defense are associated with common real-world correlates of AD and ID. Consistent with a
transdiagnostic, dimensional approach informed by the Research Domain Criteria (RDoC), 200 adults
representing the full spectrum of dispositional negativity and its subcomponents will complete a series of
behavioral paradigms that manipulate the influence of the Pavlovian learning system on instrumental behavior
in an aversive context, including a novel aversive Pavlovian-Instrumental Transfer (PIT) task. A subsample of
70 participants will complete the aversive PIT task while undergoing fMRI. Behavior will be analyzed using
frequentist multi-level models and reinforcement learning (RL) models that formally quantify Pavlovian
influence within a Bayesian decision theory framework. RL model-estimated prediction errors will be regressed
against BOLD signal, and structural equation modeling will be used to link AD, ID, and their associated
Pavlovian biases to real-world outcomes. The proposed training plan leverages a world-class research
environment with a team of highly skilled mentors and consultants to provide the candidate with training in
experimental learning paradigms, computational modeling, and functional neuroimaging methods. In line with
NIMH’s Strategic Objectives, the proposed work will describe the neural circuitry associated with complex
forms of learned defensive behavior, enable the development of clinically useful behavioral and biological
indices of dispositional negativity, and identify potential targets for transdiagnostic interventions.

Public health relevance
Dispositional negativity is a transdiagnostic risk factor for psychopathology defined by a heightened reactivity to threat and punishment that manifests in the form of frequent and intense negative affect. The present application leverages the capabilities of modern computational neuroscience to examine the latent decision processes that contribute to maladaptive threat responding in individuals with elevated dispositional negativity. Understanding the neurocomputational basis of dispositional negativity will help to facilitate the development of behavioral and computational indices that can be targeted for modification in novel transdiagnostic interventions.